Structural mechanisms of autoimmune diseases targeting cys-loop receptors

Project Summary/Abstract
Autoimmunity against neuronal receptors causes an array of diseases. Cys-loop receptors are a class
of neuronal receptors targeted in autoimmune diseases including myasthenia gravis, autoimmune encephalitis,
and autoimmune autonomic ganglionopathy. Myasthenia gravis is the longest studied; antibodies against the
neuromuscular nicotinic acetylcholine receptor were described in 1974. Autoimmune autonomic
ganglionopathy was first identified in 2000 as being associated with antibodies against the ganglionic nicotinic
acetylcholine receptors. Most recently, autoimmune encephalitis was associated with antibodies against the
related GABAA receptor. Mechanisms underlying autoimmune pathology are poorly understood but are often
attributed to receptor cross-linking and internalization. However, other mechanisms that include direct inhibition
of neurotransmission are increasingly reported. We have access to blood and cerebrospinal fluid from patients
suffering from myasthenia gravis, autoimmune autonomic ganglionopathy, and autoimmune encephalitis. Here
we propose to identify and clone autoimmune antibodies that target Cys-loop receptors. We will examine
functional receptor inhibition by patient-derived antibodies using electrophysiology. We will produce antibody
fragments to determine structures of the antibody-receptor complexes from different autoimmune diseases.
These structures combined with functional interrogation will illuminate conserved and divergent mechanisms of
autoimmune disease in this important protein superfamily. This work will lay the foundation for expansion to
other targets of the Cys-loop receptor family and beyond.

Public health relevance
Narrative We propose to study how autoimmune antibodies interact with neurotransmitter receptors to cause disease. We are specifically interested in a subset of neurotransmitter receptors that are targeted in autoimmune encephalitis, autoimmune autonomic ganglionopathy, and myasthenia gravis. The proposed studies will illuminate mechanisms of autoantibody interference with this important group of proteins and enable more targeted therapeutics of these devastating diseases.